2022 American Society for Matrix Biology Workshop on Fibroblasts: The Many Faces of Fibroblasts

PROJECT SUMMARY
The American Society for Matrix Biology (ASMB), founded in 2000, promotes the field of extracellular matrix
(ECM) biology to advance knowledge and inspire translation of ECM-centric science to improve human health
in the face of aging and disease. ASMB supports biennial workshops that are of similar scale and scope to
individual Gordon Research Conferences and Keystone Symposia. The overarching goals of these workshops
are to delve into key topics that are timely and of particular relevance to matrix biology. The theme of the 2022
ASMB Workshop is the Many Faces and Functions of Fibroblasts. The specific aims of this R13 application
are (Aim 1) to disseminate and share new knowledge about fibroblast biology, their heterogeneity, the patterns
of phenotypic differentiation, and how to quantitatively measure fibroblast outcomes; (Aim 2) to promote the
educational growth and careers of young scientists; and (Aim 3) to promote the careers of women and under-
represented minorities. To achieve these aims we have assembled a slate of world experts in the field of
fibroblast biology, from cellular profiling and developmental origins to their heterogeneity and diversity in
disease progression. Young scientists will be featured as prominently as possible in the available talks
selected from abstracts and a mentoring session is included in the meeting schedule and three travel awards
are being offered to support young investigators’ travel to the conference. Finally, the representation of women
and minority scientists in the slate of invited speakers and moderators altogether is 59%. These Aims are
consistent with the mission of the NIH and the goals of the R13 funding mechanism. R13 funds will be
primarily allocated to partially support travel and housing expenses of keynote speakers, travel awards, and
conference rental and A/V support to ensure a successful meeting.

Public health relevance
PROJECT NARRATIVE The American Society for Matrix Biology 2022 Workshop on Fibroblasts: The Many Faces and Functions of Fibroblasts will be held on October 23-25, 2022 in Charlottesville, VA at the University of Virginia. We have assembled a slate of world experts in the field of fibroblast biology, from cellular profiling and cellular crosstalk to their heterogeneity and diversity in disease progression to address critical questions and unknowns about this enigmatic cell type in tissue homeostasis and disease progression.